Lipidomics Shared Resource

LIPIDOMICS SHARED RESOURCE (LSR): SUMMARY
The Lipidomics Shared Resource (LSR) mission is a specialized facility that provides state-of-the-art
technology and resources to study complex lipid metabolism and signaling. Its mission is to support Hollings
Cancer Center (HCC) members and the scientific community by offering state-of-the-art instrumentation and
cost-effective services to identify bioactive lipids and their roles in tumor cell biology, as well as to discover and
evaluate drugs that target these pathways. The LSR is organized into three units: the Analytical, Synthesis,
and MALDI-Imaging Units. It is directed by Besim Ogretmen, PhD (DCT), a renowned lipid biologist with
expertise in sphingolipids and glycosphingolipids. The LSR is unique and the only NCI cancer center-affiliated
lipidomics facility with combined analytical, synthetic, and imaging capabilities. This is enabled by state-of-the-
art technology, including Thermo TSQ-50003, SCIEX Q-Trap triple quadrupole/ion trap, Advion TriVersa
Nanomat, Bruker Faltonics AutoFlex III linear MALDI, and AutoFLexIII MALDI TOF-TOF. The LSR is highly
integrated with HCC and its research programs, as well as other NCI-designated cancer centers. It has
become a nationally and internationally recognized scientific resource for academic and commercial
organizations outside of HCC. It has integrated matrix-assisted laser desorption/ionization (MALDI) imaging
capability for direct tissue analysis of sphingolipid and glycolipid species in tissues, drug distribution in tumor
xenograft tissue and organs (brain, kidney, liver), and structure confirmation of drug or metabolites of interest
by collision-induced fragmentation. Thus, by combining mass spectrometry and MALDI imaging, this resource
not only quantifies sphingolipids, glycolipids, free fatty acids, and prostaglandins in tissues but also provides
information about their cellular location and distribution. LSR works with investigators to continually develop
and validate new reagents and protocols in emerging fields related to lipidomics and cancer. By providing deep
exploratory and high throughput lipidomic options to analyze cancer cells and tissues, combined with
educational workshops, LSR serves a significant number of users, fostering interactions among basic, clinical,
and population scientists at HCC as well as many other cancer centers. During the current cycle, LSR directly
supported 151 investigators, resulting in impactful discoveries, top-tier publications, programmatic grants, and
clinical studies. LSR is highly integrated with HCC research through effective communication of available
services and expertise, as evidenced by the prevalence of lipidomics-related science and data in cancer center
publications and investigator-initiated clinical trials. The future goals and impact of LSR include advancing and
supporting important emerging scientific disciplines for HCC members and the broader scientific community to
help them understand lipidomics, metabolomics, and their involvement in cancer progression.